Cooperative roles of FHA and ACT in Bordetella virulence

Summary/Abstract
Pertussis (aka whooping cough) is re-emerging in developed countries despite high vaccine coverage.
Resurgence is due primarily to waning immunity to the causal bacterium Bordetella pertussis (Bp) in adolescents
and young adults immunized with acellular (aP) pertussis vaccines. Moreover, while aP vaccination protects
against disease, at least initially, it does not protect against colonization or prevent transmission, which puts
infants, who are most vulnerable to serious and sometimes fatal disease, at greater risk. New vaccines that
protect against both colonization and disease are needed. Their development requires a better understanding of
the molecular mechanisms underlying Bp virulence.
A strictly human-adapted pathogen, Bp is extremely closely related to Bordetella bronchiseptica (Bb),
which infects nearly all mammals. Bp and Bb produce a nearly identical set of virulence factors, some of which,
including filamentous hemagglutinin (FHA) and adenylate cyclase toxin (ACT), are functionally
interchangeable. FHA is a critical adhesin, a component of acellular vaccines, and the prototypical member of
the Two Partner Secretion (TPS) family. Using Bb and its natural hosts (rats and mice), we showed that in
addition to mediating adherence to host cells, FHA plays important roles in controlling the initial inflammatory
response to infection and in mediating defense of the bacteria against clearance by phagocytic cells, which
contributes to persistence in the lower respiratory tract (LRT). Our work on the mechanism of secretion and
processing of the “precursor” FhaB protein to FHA has led to major advances in the mechanism of two partner
secretion, and we showed that FhaB itself, rather than FHA, is critical for bacterial persistence in the LRT. ACT
also contributes to bacterial persistence in the LRT by mediating defense against phagocytic cell clearance.
We and others have shown that ACT binds to FhaB/FHA on the bacterial surface. We propose a model in
which ACT, while bound to FhaB on the bacterial surface, binds to CR3 on phagocytic cells, triggering
degradation of the C-terminal, periplasmically-located, FhaB prodomain, resulting in efficient delivery of ACT to
phagocytic cells and not to epithelial cells. We propose to: 1) Investigate the roles of DegP, CtpA, EnvC and
LbcA in regulated degradation of the FhaB prodomain, 2) Investigate the relationship between ACT binding to
CR3, regulated degradation of the FhaB prodomain, and delivery of ACT specifically to phagocytic cells, and 3)
Investigate the consequences of dysregulated FhaB prodomain degradation on the establishment and
maintenance of respiratory infection.

Public health relevance
Narrative Pertussis (aka whooping cough) is a serious childhood disease that is re-emerging in developed countries despite high vaccine coverage, due to inadequacies of current acellular (aP) pertussis vaccines. We are investigating how two major Bordetella virulence factors, filamentous hemagglutinin (FHA) and adenylate cyclase toxin (ACT), cooperate to minimize inflammation and inactivate host phagocytes, contributing to bacterial persistence in the lower respiratory tract. Our results will provide insight needed to develop more efficacious vaccines and therapeutics.